HistoneScan™: a multiplex immunoassay for histone epigenetic profiling

ABSTRACT
Gene activity is controlled by histone proteins that interlink with DNA molecules to form condensed chromatin
structures. Changes in these histones are thus associated with dysregulated biological processes and disease.
To date, DNA technologies lack biochemical tests proficient in detecting two or more histone modifications within
the same molecule. The use of histone-specific antibodies confers detection of a limited number of histone
modifications and thus complex modification patterns are not picked up effectively. Cross-reactivity occurring
within similar protein sequences is an additional limitation of these current assays.
In aims of enhancing detection, identification and quantification of complex human histone modifications, we
propose the development of a multiplex analytical assay HistoneScan™. HistoneScan™ technology involves
initial generation of histone fragments that comprise the histone modification of interest by means of sample
digestion. Antibodies immobilized to specific beads are then used to capture modified proteins via a technique
known as single bead immunoaffinity capture; and incorporation of several beads for one antibody allows for
assay reproducibility. Beads are then aligned onto a BAMS™ slide to enable peptide extraction from their
respective beads for analysis by mass spectrometry; by which data analysis determines relative proportions of
specific histone modification combinations.
In this research project, we propose to develop antibody-bead probes for capture of up to 100 modifications
within human histone proteins H1, H2A, H2B, H3 and H4 and to develop a histone extraction and digestion
technique for optimized HistoneScan™ workflow. Moreover, we aim to enhance data reporting by development
of an analytical software, HistoneView™, and the validation of HistoneView™ as a screening technique to be
used for chromatin profiling applications. This technique overrides the main disadvantage of current assays, i.e.,
Western blots; that are designed to only measure single protein changes and shifts to revealing co-occurring
histone modifications in a high-throughput and cost-effective direct approach. The additional use of BAMS™
technology will also allow for the detection of histone modifications that typically serve as useful disease
biomarkers, such as histone-modifying enzymes and thus pioneer the way forward in personalized medicine.

Public health relevance
NARRATIVE This project aims to develop an analytical assay kit, which will detect, identify and quantify multiple co-occurring post-translational modifications to the proteins that support DNA and regulate gene transcription. These modifications are increasingly being used as disease biomarkers. Our technology will lead to a more robust method of identifying and validating these biomarkers for precision medicine.